Early development of higher visual motion area PSS mechanisms and consequences

The standard model for development assumes that areas develop sequentially, in a feedforward manner
starting with primary visual cortex (V1). However, there is a notable exception: Primate motion area MT, and its
homolog PSS in the ferret, develop as early as V1. Early phases of development should therefore not be seen
as being under the control of V1 only, but will be jointly influenced by V1 and MT/PSS. To appropriately
incorporate this idea into developmental models, however, a precise understanding of how the areas interact
during develop is required. Should MT/PSS largely be seen as a secondary stage that filters developmental
drive received from V1, or are the areas interacting in a more complex way, which ultimately would result in
more flexibility for how development could propagate through the visual hierarchy? Here, we will investigate
the interactions between ferret PSS and V1, during an early phase of visual development in which selectivity
for motion direction develops, to address this question. Our experiments will use retrograde tracers,
extracellular recordings, and manipulations of neural activity (inactivation and stimulation) to test two
questions: First, whether PSS can function in a V1-independent manner, almost like a primary area, during this
developmental phase. Second, whether feedback from PSS plays a role in V1 development, a reversal of the
standard assumptions that would also mean that V1-PSS interactions will impact even the most fundamental
level of visual processing. The overarching goal of this proposal is to expand developmental models from
focusing on a single area at a time, to a network-wide view, a necessary step to capture the complexity of a
process that ultimately occurs at the network level.

Public health relevance
Certain higher visual motion areas have been found to mature surprisingly early, as early as the primary visual cortex. Developmental models will therefore need to include their action, in addition to that of the primary visual cortex, to appropriately capture the forces shaping early visual development. To fill this gap and improve our understanding of the mechanisms responsible for normal development, this project focuses on the interaction between primary visual cortex and higher motion area PSS during early visual development in the ferret.